Core--Leadership

DESCRIPTION (provided by applicant): This resource will provide the central organizational, operational, oversight coordination, and biostatistical support for the Program Project. It includes the Principal Investigator, the Co-Principal Investigator, and a Coordinator of Molecular Array Technology. Drs. Norton and Massague, who have complementary training and overlapping interest in clinical and laboratory science, respectively, will be responsible for the planning, execution, monitoring, and evaluation of the Program, communication with NCI, and preparation of applications and reports. They will also review all submissions for publication. Dr. Norton or, in his absence, Dr. Massague, will chair the monthly meeting of the program and organize the annual retreat. They will manage day-to-day operations with the assistance of secretarial and administrative personnel provided by the institution.